PEABI 377 DNA SEQUENCER WITH XL UPGRADE

The MCV-VCU DNA Core laboratory has experienced rapid growth each year since its inauguration in 1986 with the acquisition of our first automated DNA synthesizer. The Laboratory serves over 50 research programs on the MCV-VCU campus We have offered automated DNA sequencing services since 1989, and this service has experienced a rapid increase in demand in the last three years; i.e., demand doubled in 1995 and increased by over 30% in 1996, and our single ABI373A sequencer is running at approximately 75- 80% of its practical capacity. Projections for 1997 and 1998 will outstrip current capacity. In addition, several MCV-VCU labs have begun extensive genotyping, microsatellite analysis, gene linkage analysis, gene identification, and mutation analysis projects in the last two years. Currently, automated genotyping services are not available at MCV-VCU. Thus, the institution has elected to establish a service utilizing the automated fragment sizing capabilities of the PE/ABI 377 Prism Automated DNA Sequencing System. The specific aims of this proposal for the acquisition of this instrument are: 1. To expand the sequencing capabilities of the Core to permit high throughput processing of sequencing samples and long sequencing reads that are now the technological standard. 2. To expand the capabilities of the DNA Core into the areas of genotyping, mutation detection and mapping using the enhance GeneScan software now available. The University has committed significant resources to this, including the recent expansion of the DNA Core, the funding of a position for a technical assistant to permit the Core to expand its operations, and a commitment to providing for the installation and long term maintenance of the instrument. Acquisition of this new instrument is an integral and essential part of the planned expansion of Core Lab operations. There is simply no way that the Core can offer the additional services without the acquisition of an additional sequencer and the addition of a new technical assistant.